Bioinformatics and Pathways Core

ABSTRACT BIOINFORMATICS & PATHWAYS CORE
The Bioinformatics and Pathways Core (BPC) will support users with bioinformatics analysis of high-
throughput experiments such as RNA-seq, ChIP-seq, and genomic analyses, and provide statistical support in
both the design and interpretation of experiments. During Phases I and II of this COBRE, BPC support has
helped substantially to increase the competitiveness of Project Lead grant applications, based upon reviewer
feedback. The BPC is led by Dr. Jonathan Wren, a bioinformatician with 19 years of experience and includes a
dedicated Ph.D.-level Statistician and a Bioinformatics Scientist. Our Specific Aims are:
Aim 1: Create a cost-effective resource for high-quality, advanced data analysis services, employing
both fee-for-service and collaborative models. BPC personnel have extensive experience using state-of-
the-art bioinformatics methods, as well as a track record of developing novel analysis methods. We will provide
support for pre-experimental study design, including power analyses and utilize novel bioinformatics and
statistical tools to solve specific biological questions posed by COBRE participants. The Core Director has
developed a number of novel tools, such as software to: 1) Automate the identification and analysis of related
entities of interest (e.g., genes, diseases, phenotypes, etc.) within the published literature; 2) Identify features,
properties and experiments that overlap with genomic regions of interest; 3) Identify and analyze experiments
in public microarray databases like NCBI’s Gene Expression Omnibus (GEO) through meta-analysis and 4)
Interpret differentially expressed genes in terms of the correlations between them within public databases.
Aim 2: Provide a set of experienced analysts with a diversity of skills and expertise to accommodate a
variety of future analysis projects. This COBRE has enabled the BPC to develop novel software and to hire
personnel with a set of skills broadly useful to helping biomedical researchers. And, as evidenced by our
collaborative publications during COBRE Phases I and II, we have been successful at using our capabilities to
help others advance their research. Phase III will enable us to establish a self-sustaining institutional Core.
Aim 3: Continue to develop, evaluate, and refine new methods of data analysis and data integration.
The BPC will develop increasingly sophisticated and powerful technologies that evolve with the demands of
scientific investigators. We will improve tracking of resource utilization, advance technologies that improve
online interactivity between the data provided and our analysis of it, help investigators make their data
compliant with FAIR principles, develop methods for evaluating network-based data cohesion, and advance
machine-learning methods for common image analysis tasks.